Ultrasonic perfusion imaging of peripheral vascular disease

Project Summary
Our 4-yr project aims to develop a new ultrasonic Doppler method named Higher-Order Perfusion Estimation
(HOPE) imaging. Applications enabled by this technology are routine assessments of microvascular disease
progression in diabetic patients with symptoms of peripheral artery disease (PAD). Technical advances include
new ultrasonic echo sampling and filtering techniques that significantly increase the sensitivity and specificity of
standard sonographic instruments to spatially disorganized patterns of red-blood-cell movement without the
addition of contrast media. Sensitivity to slowly perfusing blood is increased by transmitting a sparse regular
sequence of Doppler pulses over long durations (1-10s). To counter a concomitant increase in clutter-signal
power in perfusing-blood frequency channels, spatiotemporal echo acquisitions are first rearranged into 3-D data
arrays and a 3-D singular-value decomposition (3D-SVD) clutter filter is formed for each experiment. Our
approach now successfully separates weak perfusing-blood echoes from other echo-signal sources in the
peripheral vasculature because of the typically narrow eigen-bandwidth of clutter echoes in peripheral muscle.
Preliminary results using echo simulation, microchannel flow phantoms, and preclinical models of mouse
ischemic hindlimb and melanoma lesions demonstrate that our method is very well designed for monitoring
steady peripheral microvascular flow patterns using commercial ultrasonic instruments (with software updates).
Four aims are proposed to demonstrate the utility of HOPE imaging (both power and color-flow) for measuring
blood flow and perfusion. Aim 1 expands preliminary studies in mouse models to evaluate perfusion
measurement sensitivity at 12-24 MHz in diabetic animals, and to uncover mechanisms of the angiogenic
response of tissues to sudden ischemia. Aim 2 continues development of HOPE imaging by improving perfusing-
blood echo sensitivity and clutter-filter performance under more general imaging conditions (viz., broad eigen-
bandwidth clutter and 3-D spatially varying perfusion). Aim 3 focuses on a progressively ischemic pig model
using 5-12 MHz HOPE imaging, MR angiography, and radioactive microsphere techniques to calibrate and
compare HOPE imaging results with standard clinical approaches. Aim 4 is a 4-yr, 150-patient study designed
to evaluate the diagnostic performance of HOPE imaging at assessing PAD. The overall project aims to develop
existing ultrasonic instruments into highly-effect tools for evaluating microvascular changes leading to common
disabilities and major cardiovascular events. The three in vivo studies proposed in this plan are designed to
develop and evaluate HOPE imaging specifically for PAD diagnosis, staging, and therapeutic monitoring.

Public health relevance
Project Narrative The project leverages a new understanding of the information contained within Doppler ultrasound echo signals to create a more effective diagnostic tool for imaging microvascular changes associated with peripheral arterial diseases. Success in this project brings effective new methods to existing instruments enabling medical professionals to track peripheral microvascular decline as well as treatment responses. This safe, low-cost method can also be applied to patients frequently helping them directly observe the effects of lifestyle decisions.